Spatially resolved mapping of lineage and signaling history in human skin organoids

Project Summary
Differentiation and tissue growth are both dependent upon faithful adherence to programs that
encompass lineage hierarchy, spatial location, and integration of signaling information. By deciphering these
programs, biologists have increasingly been able to generate diverse model tissues from cell lines such as
immortalized keratinocytes. This has allowed scientists to study processes that were previously confined to the
human body such as wound healing in interfollicular epidermis. Despite the fidelity of progenitor cells to the
programs that govern growth, it has been well documented that individual clones expand to different degrees
and have immensely variable contributions to tissues. In the context of homeostasis, it is poorly understood
which signaling pathways, lineage trajectories, and spatial microenvironments drive clonal dominance. The
methods (optical lineage tracing and RNA sequencing) and model systems (mice) often used to study clonal
expansion provide an incomplete picture of this phenomenon in human skin development.
To address these shortcomings, our lab has recently developed two prime-editing based molecular
recording platforms that record the precise order in which cells experience biological events, termed ENGRAM
(ENhancer-driven Genomic Recording of transcriptional Activity in Multiplex) and DNA Typewriter. With their
combined application, the lineage and signaling history of a cell may subsequently be read out via
high-throughput sequencing.
In this proposal, I aim to further develop and deploy these molecular recording systems systems in a
well characterized human model of skin development, an immortalized keratinocyte-derived epidermal
organotypic model, to study epidermal fate specification and clonal competition. Through polony-indexed
library-sequencing (Pixel-seq), a high-resolution spatial transcriptomics method, I will generate maps of clonal
growth with corresponding measurements of each clone’s signaling and lineage history in the context of its
spatial microenvironment. I will utilize these data to answer fundamental questions about the drivers of clonal
competition in homeostatic epidermis, and will in the process generate immortalized keratinocyte lines for
downstream use in organoid and disease models.

Public health relevance
Project Narrative During differentiation and growth, contributions of individual progenitor cells to tissues such as the epidermis are immensely heterogeneous. However, it is currently poorly understood which spatial microenvironments, signaling pathways, and lineage trajectories govern clonal competition due to the difficulty of measuring these determinants simultaneously with current methodologies. To overcome these limitations, this proposal aims to apply signal and lineage recording with spatial-sequencing to a keratinocyte derived model of organotypic epidermis to identify the spatiotemporal drivers of clonal competition during skin growth.